Targeting kidney resident macrophage niche filling to slow cystic kidney disease

Project abstract
Our data indicate that kidney resident macrophages (KRM) promote cystic kidney disease in multiple mouse
models and that a similar population of KRM are present in humans suggesting that targeting these cells in
patients with cystic kidney disease may have significant therapeutic benefits. However, it is not feasible to give
patients KRM targeted inhibitors for long periods as these inhibitors deplete resident macrophages in multiple
tissues, where their presence is required for basic biological functions including recycling red blood cells and
fighting off infections. This problem is particularly relevant in the case of cystic kidney disease as patients
experience periods of intermittent cyst growth over several decades. These data highlight the fact that a tissue
specific approach to deplete KRM is desperately needed. In this application, we are proposing to study niche
filling as a means to developing a tissue specific approach for long-term resident macrophage depletion.
However, before we can accomplish this goal, we must first understand the mechanism of niche filling after
temporary depletion, genes that are required for this process, and the influence of temporary depletion on long-
term cyst growth. Based on our preliminary data, we hypothesize that Cx3cr1 is required for monocyte-
dependent niche filling and cyst progression. This hypothesis will be tested using a monocyte-specific fate
mapping mouse to track monocyte recruitment and engraftment into the KRM niche after depletion in both wild
type and cystic mice. In subsequent aims, we will identify genes that are required for this process and test the
idea that we can target a candidate gene, Cx3cr1, to delay KRM niche filling and slow cystic disease. Based on
our exciting preliminary data, we propose that targeting Cx3cr1 may lead to a kidney specific approach for long-
term resident macrophage depletion. This would have major impact on the cystic kidney disease field as well as
any field in which KRM are involved in disease progression. This includes acute kidney injury and chronic kidney
diseases, both of which are a major healthcare burden.
1

Public health relevance
Project Narrative Our lab demonstrated that KRM accelerate cyst growth in multiple animal models of cystic kidney disease and are also present in patients with accelerated rates of renal function decline making KRM- targeted therapeutics highly desirable; however, it is not feasible to give patients resident macrophage targeted inhibitors for long periods as these inhibitors deplete resident macrophages in other tissues where they are needed for basic biological functions. In this application, we seek to identify a tissue specific approach for long- term KRM depletion by studying the mechanism of KRM niche filling after depletion in wild type and cystic mice. If successful, these data would provide a novel approach to target KRM in patients with cystic kidney disease or any other disease that involves KRM including acute kidney injury.